NRG Oncology Annual BIQSFP Progress Reports

N/A
This is a BIQSFP annual progress report.

Public health relevance
NRG-HN001 Yr 11S Progress Report NCI CCCT Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) Instructions for Submitting Annual Progress Report NOTE: ANNUAL PROGRESS REPORTS ARE REQUIRED FOR BIQSFP BUDGET APPROVAL AND CONTINUED FUNDING. PLEASE PROVIDE THE INFORMATION REQUESTED BELOW WITHIN THE TYPE 3 ADMINISTRATIVE SUPPLEMENT APPLICATION SUBMISSION FOR GY11 Extended period. Deadline for submission is March 17, 2025. Information requested for annual progress report:  BIQSFP Project title: Integral determination of pre- and post-treatment EBV DNA in EBV+ nasopharyngeal carcinoma for risk group stratification  BIQSFP entire project duration: ___2020________ (initial year of project) to ____2024_________ (final year of project)  Total # of patients tested to date (from project start) ___828__; Total # of patients planned for entire project __828_  Total # of patients tested during the past grant year only____0_____  # of assays/tests completed during reporting period if different from # of patients tested (e.g., multiple time points are tested per patient). assay/test name and testing time points_________________________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ (insert additional lines as needed)  Are patient accrual and completion of BIQSFP-funded assays/tests progressing on schedule? If “no,” please explain. COMPLETED  Do you anticipate a need to extend the study period? If “yes,” please explain. NO  Were there any unanticipated issues that negatively impacted conducting the BIQSFP-funded assays/tests within projected turn-around time? If “yes,” please explain. NO  Are there any other issues or concerns that should be brought to NCI's attention? NO The final progress report will be submitted when the primary endpoint analysis is reported. No further funds will be expended on this project. The unobligated balance is $0. March 2025 NCI CCCT Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) Instructions for Submitting Annual Progress Report NOTE: ANNUAL PROGRESS REPORTS ARE REQUIRED FOR BIQSFP BUDGET APPROVAL AND CONTINUED FUNDING. PLEASE PROVIDE THE INFORMATION REQUESTED BELOW WITHIN THE TYPE 3 ADMINISTRATIVE SUPPLEMENT APPLICATION SUBMISSION FOR GY11 Extended period. Deadline for submission is March 17, 2025. Information requested for annual progress report:  BIQSFP Project title: pHH3 Mitotic Index as an Integrated Marker (NRG-BN003)  BIQSFP entire project duration: ____2017___ (initial year of project) to ____2025______ (final year of project)  Total # of patients tested to date (from project start) __202___; Total # of patients planned for entire project __222_  Total # of patients tested during the past grant year only__17_____  # of assays/tests completed during reporting period if different from # of patients tested (e.g., multiple time points are tested per patient). assay/test name and testing time points________ ____________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ (insert additional lines as needed)  Are patient accrual and completion of BIQSFP-funded assays/tests progressing on schedule? If “no,” please explain. (NO – See Below)  Do you anticipate a need to extend the study period? If “yes,” please explain. o Accrual is expected to be completed by the end of Grant Year 11S  Were there any unanticipated issues that negatively impacted conducting the BIQSFP-funded assays/tests within projected turn-around time? If “yes,” please explain. o No  Are there any other issues or concerns that should be brought to NCI's attention? o The sample size for this trial was increased from 133 to 163 patients in a June 2022 protocol amendment due to the higher number of patients than expected withdrawing consent for treatment with RT on the trail. Based on current screening patterns it is expected that 222 patients will be needed to meet the new sample size for the intervention step March 2025 NRG-BN003 Integrated Biomarker BIQSFP Year 11S Progress Report – Budget Justification Budget Justification – pHH3 Analysis Funding was awarded to support an integrated biomarker study for NRG-BN003, “Phase III Trial of Observation versus Irradiation for a Gross Totally Resected Grade II Meningioma,” which opened to accrual in June 2017. The BIQSFP supports the NRG Oncology Biobank at the University of California San Francisco (BB-UCSF) to perform the central histology review and prepare and at the end of the study ship the biospecimens to Dr. Aldape at the NCI where he will determine if pHH3 can be used as a biomarker to predict overall and progression-free survival in patients with gross totally resected Grade II Meningioma. It was originally projected that 148 patients would need to be enrolled and screened to provide the 133 randomized cases required for the primary endpoint analysis. In June 2022 the original sample size was increased from 133 cases to 163 due to the higher number of patients withdrawing consent for treatment on the RT arm. Based on current screening patterns it is expected that 222 patients will need to be enrolled/screened to provide 163 randomized patients. Based on current accrual patterns it is expected that the required number of patients will be enrolled by the end of grant year 11S. It is not expected that an increase in the total amount of funding approved for this study will be required as it is no longer required to fund Dr. Aldape's effort since he is at the NCI and NRG Oncology's indirect rate has changed resulting in a decrease in the amount of funds that need to be allocated in that category. Continued funding is requested to support the BB-UCSF for the collection and central pathology review of the remaining cases and for the shipping of the materials to NCI at the conclusion of the study.  It is anticipated that 22 patients will be screened during grant year 11S for a total cost of $10,280. Budget The NRG Oncology Biobank at the University of California San Francisco (UCSF) receives all biospecimen materials submitted for NRG-BN003 including the specimens required for the pHH3 analysis at Dr. Aldape's laboratory at NCI. UCSF will prepare and ship the specimens required for the pHH3 analysis in batches at the end of the study. Support is requested for the central pathology review at UCSF and UCSF's preparation and shipping of the materials to NCI as detailed below. Prices listed are the maximum cost per case depending upon services needed. Central Pathology Review Cost per Case H&E Slide Staining (as needed) $15.85 Receiving and processing cases for Central Review $55.48 Problem Cases: missing paperwork, block, H&Es $55.48 Return requests, ineligible case return, punch and return $55.48 Subtotal Max per case $182 Aperio Recharge Scanning if needed for remote review $26 Budget – see below March 2025 NRG-BN003 Integrated Biomarker BIQSFP Year 11S Progress Report – Budget Justification Cost Grant Year 11S 2025 Projected # Cases Accrued 22 Central Pathology Review @ $182 / case $ 182 $ 4,004 Aperio Review of 4 cases/ year @ $26 $ 26 $ 572 pHH3 Slide Prep & Shipping for 133 Cases $ 40.84 $ 5,432 pHH3 Central Testing @ NCI $ - Total Direct Costs $ 10,008 NRG Oncology IDC* $ 272.22 Total Yearly Costs $ 10,280 Total Cost IDC Rate 2.72% March 2025 NCI CCCT Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) Instructions for Submitting Annual Progress Report NOTE: ANNUAL PROGRESS REPORTS ARE REQUIRED FOR BIQSFP BUDGET APPROVAL AND CONTINUED FUNDING. PLEASE PROVIDE THE INFORMATION REQUESTED BELOW WITHIN THE TYPE 3 ADMINISTRATIVE SUPPLEMENT APPLICATION SUBMISSION FOR GY11 Extended period. Deadline for submission is March 17, 2025. Information requested for annual progress report:  BIQSFP Project title: Gene expression biomarker distribution in meningioma samples from NRG-BN003  BIQSFP entire project duration: ____2024___ (initial year of project) to ____2026______ (final year of project)  Total # of patients tested to date (from project start) __0___; Total # of patients planned for entire project __222_  Total # of patients tested during the past grant year only__0_____  # of assays/tests completed during reporting period if different from # of patients tested (e.g., multiple time points are tested per patient). assay/test name and testing time points________ ____________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ (insert additional lines as needed)  Are patient accrual and completion of BIQSFP-funded assays/tests progressing on schedule? If “no,” please explain. Yes  Do you anticipate a need to extend the study period? If “yes,” please explain. o Accrual is expected to be completed by the end of Grant Year 11S and at that time all samples will be available for testing which will occur in 2026.  Were there any unanticipated issues that negatively impacted conducting the BIQSFP-funded assays/tests within projected turn-around time? If “yes,” please explain. o No  Are there any other issues or concerns that should be brought to NCI's attention? o NRG-BN003 is expected to complete accrual by the end of grant year 11S. The MTA to transfer existing samples has been executed. A protocol amendment to incorporate the testing required under the BIQSFP has been released and sites have been notified about the need to reconsent patients already enrolled on the study. This work is ongoing. March 2025 NRG-BN003 Raleigh EYO BIQSFP Year 11S Progress Report – Budget Justification NRG Oncology Gene Expression Biomarker Distribution in Meningioma Samples from NRG-BN003 David Raleigh, MD, PhD BUDGET JUSTIFICATION SUMMARY Funding is requested to support a non-real time integrated biomarker study entitled “Gene Expression Biomarker Distribution in Meningioma Samples from NRG-BN003.” The parent protocol for this study is entitled “Phase III Trial of Observation Versus Irradiation for a Gross Totally Resected Grade II Meningioma.” The NRG Oncology Biobank at UCSF will provide the specimens required for the investigators to perform their analysis. Dr. Raleigh and his team at UCSF will complete the gene expression profiling. Budget Summary Grant Year 11 - 2024 Awarded Grant Year 11S 2025 Projected # Cases 163 163 Biobank-UCSF $ 8,580 $ 8,580 Raleigh Lab @ UCSF Personnel $ 39,948 $ 39,948 Nucleic Acid Extraction @81.82 $ 13,500 $ 13,500 nanoString Profiling $ 16,300 $ 16,300 Data Network fee $ 96 $ 96 IT Services $ 185 $ 185 UCSF Direct Costs $ 78,609 $ 78,609 UCSF IDC Costs $ 49,653 $ 49,653 Total UCSF Costs $ 128,262 $ 128,262 NRG Oncology IDC* $ 2,835 $ 2,835 Total Costs $ 131,097 $ 131,097 Total Cost IDC Rate at time of application 2.21% PERSONNEL - Salary/Fringe Benefit: $39,948 David R. Raleigh, MD, PhD, Principal Investigator (Contact PI) (1.2 calendar months) is an Associate Professor in the Departments of Radiation Oncology, Neurological Surgery, and Pathology at UCSF, and the Director of the UCSF Brain Tumor Center Preclinical Therapeutics Core. He is a physician scientist and with extensive research experience in meningioma biology, including the use of bioinformatic approaches to develop biomarkers that predict meningioma biology and therapeutic vulnerabilities (Choudhury et al. Nature Genet 2022), including radiotherapy response (Chen et al. Nature Medicine 2023). He will assume the overall responsibility for the scientific and administrative conduct of this award and will design and supervise each phase of the research plan in collaboration with other personnel. William Chen, MD, Postdoctoral Scholar (.60 calendar months) is a Clinical Instructor in the Department of Radiation Oncology at UCSF. He is a physician scientist with extensive research experience in biomarker development and implementation for meningiomas (Chen et al. Neurosurg 2020, Chen et al. Nature Medicine 2023), and a member of the Raleigh Lab. In collaboration with Dr. Mirchia, he will be responsible for extracting March 2025 NRG-BN003 Raleigh EYO BIQSFP Year 11S Progress Report – Budget Justification and processing nucleic acids for bioinformatic analyses, and he will perform gene expression risk score biomarker calculations. Kanish Mirchia, MD, Postdoctoral Scholar (.60 calendar months) is a Clinical Instructor in the Department of Pathology, Division of Neuropathology, at UCSF. He is a physician scientist with extensive bioinformatic experience (Lucas, Mirchia et al. Nature Genet in press), and a member of the Raleigh Lab. In collaboration with Dr. Chen, he will be responsible for extracting and processing nucleic acids for bioinformatic analyses. OTHER: $38,661 Nucleic Acid Extraction: $13,500 These funds will be used to extract RNA from 163 samples@$82.82 using the Qiagen Allprep kit and pre-existing equipment in the Raleigh lab, a strategy that we have successfully used to process 4898 meningioma sequencing assays over the last 3 years (Chen et al. Nat Medicine 2023). nanoString Targeted Gene Expression Profiling: $16,300 These funds will support gene expression profiling of 163 samples@$100 to define a 34-gene expression risk score with known predictive significance for meningioma outcomes, including benefit of postoperative radiotherapy (Chen et al. Nat Medicine 2023). Data network fee: $96 The data network services recharge or data network recharge is a vital component of the University's Enterprise Network Services (ENS), which provides funding for critical equipment in support of UCSF's electronic information flow. Per agreement signed January 24, 2008 with The Department of Health & Human Services (DHHS), Division of Cost Allocation, (cognizant agency to the University), the University does not disclose ENS costs as F&A pool costs and can charge for ENS costs as direct costs. This cost must adhere to the UCSF Costing Guidelines for the Allowability of Computing Device Support Recharges on Sponsored Project Awards and are permissible under our approved Cost Accounting Standards Board Disclosure Statement (CASB Form DS-2) ensuring that there is no duplicate reimbursement from Federal and non-Federal sponsors. The data network recharge is based on the current rate per FTE, consistent with the current billing rates for the data network recharge. Recharge rates are computed in accordance with the requirements of 2 CFR Part 200 and will be reviewed and adjusted annually. Calculations are based on the percent effort to be charged to the project for each person named in the grant (03/01/2024- 02/28/2025: $40/month/FTE). IT field services (ITFS) desktop support: $185 On July 1, 2013, the University initiated direct charging for ITFS as an integral component of its Enterprise Network Services (ENS) to provide support to campus voice and data technology functions. ITFS includes software installation/updates, internet security, hardware setup/configuration, and centrally managed patching, storage and backup. Direct charging of these support services in conjunction with the Data Network Recharge are covered under Part 3.2.0 – Service Centers, Communication Services, of the University's Cost Accounting Standards Board Disclosure Statement (CASB Form DS-2) ensuring that there is no duplicate reimbursement from Federal and non-Federal sponsors. The ITFS charge is based on the current rate per FTE, consistent with the current billing rates for ITFS. Recharge rates are computed in accordance with the requirements of 2 CFR Part 200 and will be reviewed and adjusted annually. Calculations are based on the percent effort to be charged to the project for each person named in the grant. Biospecimen Bank Core: $8,580 Funding is additionally requested to de-archive the meningiomas from NRG-BN003 from the NRG Biospecimen Bank, which is directed by Sandy DeVries and is conveniently located at UCSF. The budget for these samples was developed in collaboration with the Biospecimen Bank, and charges will be billed through the UCSF Biospecimen & Aperio recharge service. March 2025 NRG-BN003 Raleigh EYO BIQSFP Year 11S Progress Report – Budget Justification NRGBB-SF Estimated Budget for BIQ BN003 Proposal Estimated Cost-3/5/2024- UCSF PRICES Units Max # Cases Cost each* Totals One to Two 2mm punch from Blocks for RNA 1 85 $18.50 $1,572.50 10 five micron unstained slides per patient- from Core Blocks 10 78 $7.00 $5,460.00 Eslide Imager Aperio access to pre-existing H&E images- image de-identification 1 57 $2.00 $114.00 Aperio Images at 40X (to be scanned still) 1 106 $8.75 $927.50 FFPE project management 5 163 $69.50 $347.50 Shipping- priority overnight - 2 batches 2 163 $79.00 $158.00 Estimated Total for Study $8,580 SUBAWARD DIRECT COSTS: $78,609 SUBAWARD FACILITIES AND ADMINISTRATIVE COSTS: $49,653 Listed are UCSF's anticipated F&A rates at the time of the application with the total prorated according to the time period. July 1, 2021, to June 30, 2024: 61.5% on-campus July 1, 2024, until amended: 64.0% on-campus TOTAL SUBAWARD COST: $ 128,262 NRG Oncology F&A @2.21% $ 2,835 Total Cost $ 131,097 March 2025 NCI CCCT Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) FINAL Progress Report NOTE: FINAL PROGRESS REPORTS ARE REQUIRED within 6 months of completion of the BIQSFP project including the data analysis. PLEASE SUBMIT THIS FORM UPON COMPLETION OF BIQSFP PROJECT. The Final Progress Report may also be submitted in lieu of the Annual Progress Report WITHIN THE TYPE 3 ADMINISTRATIVE SUPPLEMENT APPLICATION SUBMISSION. If sending to CCCT directly, please send to Kelly Kim at [email] and BIQSFP mailbox at [email]. Any resulting publications should acknowledge the funding source as follows: “This study was supported in whole or in part by funding from the Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) awarded by the National Cancer Institute.” *********************************************************************************** 1. BIQSFP Project Title (or Protocol Title if there is no distinct BIQSFP project title): O6- methylguanine DNA methyltransferase gene (MGMT) promoter methylation testing by MGMT-STP27 --BN007 2. BIQSFP Project PI Name: _Erik Sulman, MD, PhD________________________ Phone: ____646-501-6153________________________________________ Email:[email]___________________________ 3. BIQSFP Project Period (start and end dates): __2020_________ to __2025____ 4. Total # of patients accrued to trial __159_____ 5. Total # of patients screened or tested as part of BIQSFP project ____374______ 6. Name and description of assay(s)/test(s) (including any notable research materials, reagents, equipment, etc. that were used):  The MGMT-STP27 utilizes the Infinium Methylation Beadchip Array platform (Illumina). This platform utilizes bisulfite converted DNA purified from deparaffinized, micro-dissected tumor tissue. The platform requires a minimum of 50ng of purified DNA, typically obtained from fewer than five 5 micron sections. Arrays are scanned using the iScan platform (Illumina) and pre-processed into iDAT files using Genome Studio (Illumina).  All patients registered for the trial will be required to submit FFPE tumor tissue blocks from their primary resection with tumor material of at least 1 cm2. Following central pathology review, 10 unstained tumor sections will be obtained within areas of viable tumor identified by the study neuropathologist, Dr. Ken Aldape. DNA will be prepared using the MasterPure Complete DNA and RNA purification kit (Epicentre Biotechnologies, Madison, WI) following deparaffinization using Citrisolve (Amity International, Anderson,SC). Bisulfite conversion of DNA will be performed (Zymo EZ96 DNA methylation kit, Zymo Research) and the remainder of tumor DNA will be frozen at -20C and kept for repeat analyses, if necessary. Approximately 250ng (minimum 50ng) of bisulfite converted DNA will be treated with the Infinium HD FFPE DNA Restore Kit to repair degraded DNA. Quality control of restored DNA is assayed by real-time PCR (qPCR) of an ACTB amplicon. Samples with a threshold cycle (CT) of <28 are considered adequate for array hybridization. DNA is then processed, hybridized, washed, and stained to Infinium HD MethylationEpic Beadchip microarrays according to the manufacturers protocol. Hybridized arrays are scanned using an iScan system. Raw scan files (iDAT files) are used for downstream analysis.  Determination of MGMT methylation is done using the methylation level (M-value) of two probes on the array, cg12434587 and cg12981137, are combined in a logistic regression as follows: logit(y)=4.3215 + 0.5271 · cg12434587 + 0.9265 · cg12981137 A probability threshold of 0.358 is used to distinguish methylated from unmethylated. The R-package mgmtstp27 was used to compute the result (https://github.com/badozor/mgmtstp27). 7. List the major goals of the BIQSFP project as stated in the approved application or as later approved by NCI if any changes to the goals had to be made. The goal of the project was to conduct central pathological review and determination of MGMT status as an integral biomarker for patient randomization in the NRG-BN007 trial. 8. Please describe the biomarker/imaging/ QOL study analyses that were performed, and discuss the resulting data and conclusions (please include tables and/or figures).  In the report describing the initial construction the MGMT-STP27, 63 GBM tumor specimens and 5 non- tumor brain specimens were used to build the model. This model was then validated on an external dataset of 47 GBMs for which MDxHealth MS-qPCR status was known [1]. The reported concordance was 94% between the two assays, with sensitivity and specificity of 93% and 94%, respectively.  To further validate the MGMT-STP27 assay we compared it to the MDxHealth results on an independent set of 202 cases of newly diagnosed GBM. All cases were tested using the commercial MDxHealth assay. This is the same assay used for RTOG-0525 and RTOG-0825. The overall concordance was 93% with a sensitivity of 97% and specificity of 88%.  Given the established prognostic role for MGMT methylation in patients with GBM, we compared the survival of the MS-qPCR based assay in each dataset to the MGMT-STP27 assay (Figure 1). Median survival based on the MDxHealth assay was 19.0 months vs. 15.5 months for MGMT methylated vs. unmethylated, respectively. In comparison, the median survival based on MGMT-STP27 was 20.3 months vs. 14.7 months for methylated vs. unmethylated, respectively. The MGMT-STP27 performed better in discriminating improved survival patients from poorer survival, suggesting it might be superior as a biomarker of high-risk, TMZ-unresponsive patients. 9. Please discuss the trial outcome data, results, and conclusions (please include tables and/or figures). A total of 374 patients screened and 159 randomized. A Phase 2 analysis showed no benefit and trial closed on 6/19/2023. Study results were presented as an abstract at the European Association of Neuro- Oncology 2023 annual meeting (award-winning) in Rotterdam, The Netherlands and as an encore at the Society for Neuro Oncology 2023 annual meeting in Vancouver, Canada. A manuscript is in preparation for submission to a peer -reviewed journal. Below is a summary of the draft manuscript. ABSTRACT Purpose: New therapies for glioblastoma are needed, especially MGMT-unmethylated disease. NRG Oncology BN002 (phase I) demonstrated safety and suggested efficacy of ipilimumab with nivolumab in newly diagnosed glioblastoma, leading to this phase II/III trial. Methods: Adults with newly diagnosed MGMT-unmethylated glioblastoma and Karnofsky Performance Status (KPS) ≥ 70 were randomized to radiotherapy with either immunotherapy (ipilimumab and nivolumab) or temozolomide, stratified by recursive partitioning analysis (RPA) class and intent to use Tumor Treating Fields. With 95% power to detect a hazard ratio (HR) ≤ 0.58 for PFS at a one-sided significance level (p) of 0.15, superior PFS with immunotherapy in phase II would lead to phase III overall survival testing. Corticosteroids were disallowed when starting immunotherapy. Diagnosis, biomarkers, and PFS were centrally assessed. Results: 159 participants were randomized (79 immunotherapy, 80 temozolomide). Arms were well balanced for age (median 60 years, range 28-79), sex (male n=105, 66%), KPS (90-100 n=97, 61%), resection extent (gross total, 64.8%, n=103, 64.8%), and RPA class (III, n=16, 10%; IV, n=116, 73%; V, n=27, 17%). A pre-planned analysis of phase II data conducted after 100 centrally determined PFS events showed no significant PFS improvement for ipilimumab and nivolumab vs. temzoloomide (median 7.7 months vs. 8.5 months, HR 1.47, 95% CI 0.98-2.2, 1-sided p=0.96). Overall survival is immature (> 50% alive) but with no observed difference between arms (median OS ~13 months each, HR 0.95, 95% CI 0.61-1.49, p=0.36). Conclusion: Ipilimumab and nivolumab did not improve PFS among patients with newly diagnosed uMGMT glioblastoma vs. temozolomide. Accrual closed permanently; the trial will not proceed to phase III. No new safety signals were identified. Molecular correlative analyses and survival follow- up are ongoing. 10. Please discuss how the BIQSFP project has helped improve the clinical validity of the biomarker(s)/test(s)/QOL instrument(s). MGMT status was required to determine eligibility for the trial. 11. Did the BIQSFP project results or trial results contribute to changing or establishing new clinical practice guidelines regarding the use of the biomarkers/tests. If yes, please describe how. No 12. Did the BIQSFP project results or trial results contribute to the regulatory approval of any clinical tests either directly or indirectly? If yes, how? Please describes those test(s). No 13. Have there been other important regulatory, commercial, or coverage decision developments during or after BIQSFP project period that are relevant to the BIQSFP-funded biomarkers/tests? If yes, please describe. No 14. Were there any new grant projects or other studies that were pursued or are planned, as follow- up to the BIQSFP-funded biomarker study? If yes, please describe. Central determination of MGMT status continues to be required for several ongoing NRG Oncology trials. 15. Were any other accomplishments related to the BIQSFP-funded project. If yes, please describe. No 16. Were there any unanticipated issues or problems that negatively impacted the completion of the BIQSFP project on schedule? If “yes,” please explain. What was learned from the experience? No 17. If the BIQSFP project outcomes or the trial outcomes were not as expected, or if the stated goals were not met, please discuss what the deficiencies may have been and or what different approach could be tried in the future. The MGMT testing proceeded as expected for the trial. Unfortunately, the trial closed after analysis of the Phase 2 results showed no potential benefit. 18. List of publications resulting from the BIQSFP project: Lassman AB, Polley MC, Iwamoto FM, Sloan AE, Wang TJ, Aldape KD, Wefel J, Gondi V, Gutierrez AN, Manasawala M, Gilbert MR, Sulman EP, Wolchok JD, Green RM, Neil E, Lukas RV, Goldlust SA, Snuderl M, Dignam JJ, Won M, Movsas B, Mehta MP. NRG Oncology Study BN007: Randomized phase II/III trial of ipilimiumab (Ipi) plus nivolumab (Nivo) vs. temozolomide (TMZ) in MGMT-unmethylated (uMGMT) newly diagnosed glioblastoma (nGBM). EANO (European Association of Neuro-Oncology). 9/21/2023. PL02.3.A Lassman AB, Polley MC, Iwamoto FM, Sloan AE, Wang TJ, Aldape KD, Wefel J, Gondi V, Gutierrez AN, Manasawala M, Gilbert MR, Sulman EP, Wolchok JD, Green RM, Neil E, Lukas RV, Goldlust SA, Snuderl M, Dignam JJ, Won M, Movsas B, Mehta MP. NRG Oncology Study BN007: Randomized phase II/III trial of ipilimiumab (Ipi) plus nivolumab (Nivo) vs. temozolomide (TMZ) in MGMT-unmethylated (uMGMT) newly diagnosed glioblastoma (nGBM). SNO (Society for Neuro-Oncology). 11/18/2023. Manuscript in progress. 19. Unobligated balance estimate (from prior grant year's awarded budget): $0 20. Report submitted by: _______________________________________ Date: _3/17/2025_______ Email: [email]_ Phone: __(646) 501-6153____________ NRG-HN006 Year 11S Annual Progress Report NCI CCCT Biomarker, Imaging, & QOL Studies Funding Program (BIQSFP) Instructions for Submitting Annual Progress Report NOTE: ANNUAL PROGRESS REPORTS ARE REQUIRED FOR BIQSFP BUDGET APPROVAL AND CONTINUED FUNDING. PLEASE PROVIDE THE INFORMATION REQUESTED BELOW WITHIN THE TYPE 3 ADMINISTRATIVE SUPPLEMENT APPLICATION SUBMISSION FOR GY11 S period. Deadline for submission is March 17, 2025. Information requested for annual progress report:  BIQSFP Project title: Determining Negative Predictive Value of FDG PET/CT for N0 Neck in T1- T2 Oral cavity SCC Patient  BIQSFP entire project duration: 2020 (initial year of project) to 2025 - (final year of project)  Total # of patients tested to date (from project start) 237; Total # of patients planned for entire project 1055 (Ph III)  Total # of patients tested during the past grant year only 79  # of assays/tests completed during reporting period if different from # of patients tested (e.g., multiple time points are tested per patient). assay/test name and testing time points______FDG PET/CT________________ # tests completed 82 assay/test name and testing time points_________________________________ # tests completed _______ assay/test name and testing time points_________________________________ # tests completed _______ (insert additional lines as needed)  Are patient accrual and completion of BIQSFP-funded assays/tests progressing on schedule? If “no,” please explain. PHASE II Completed  Do you anticipate a need to extend the study period? If “yes,” please explain. MAYBE*  Were there any unanticipated issues that negatively impacted conducting the BIQSFP-funded assays/tests within projected turn-around time? If “yes,” please explain. NO  Are there any other issues or concerns that should be brought to NCI's attention? NO *The BIQSFP was submitted for a Phase II/III trial. We have completed the accrual for the Phase II study and the study is now paused for maturity of outcome results and analysis before a GO/No Go decision is made in June/July of 2025 based on the analysis of the Phase II results. If a NO GO decision is made and the trial is completed, we will refund leftover funds; if a GO decision is made to move forward with the Phase III trial, we will continue (and, if it is decided to add a third arm to the Phase III, amend the protocol and submit a new budget for supplemental funding). March 2025 NRH HN006 Integral Imaging BIQSFP Year 11S Progress Report –Budget Justification BUDGET JUSTIFICATION – FDG PET/CT Funding has been awarded to support integral FDG PET/CT scans and real-time central review for NRG-HN006, “Randomized Phase II-III Trial of Sentinel Lymph Node Biopsy Versus Elective Neck Dissection for Early-Stage Oral Cavity Cancer.” The primary objective of the BIQSFP is to provide PET/CT scans required for eligibility of patients and to establish the negative predictive value of FDG PET/CT for N0 neck in T1 oral cavity squamous cell cancer patients in the END arm. In order to be eligible for the study, patients must have a clinical and radiographic N0 neck (CT or MRI). The assessment of the N0 neck will include FDG PET/CT scan...